Community Partners

Summary
The central theme running through the center’s research projects and training program is
consistent and robust communication across community partners and to and with mothers.
Each community partner represents a node or access point to a larger web of community
networks. These networks are necessary to garner community buy-in and engagement that
amplifies community voices, needs, and resources. As liaisons, our community partners will
ensure community member access to each stage of the center’s research projects and training
program, including conceptualization, planning, execution, assessment, and dissemination.
The first research project will develop and adapt an evidence-based community worker home
visiting program that is grounded in extensive patient and community participation as well as
partnerships with community organizations in healthcare, mental health, social work, and
child/lactation support. The second research project will evaluate the effectiveness of a
multilevel and multisectoral communication and health literacy strategy to increase trust and
engagement in postpartum healthcare, through partnerships with community organizations in
healthcare, racial and economic justice, and health policy. Supporting the goals of the research
projects, an extensive research training program for early-stage investigators will address the
interpersonal and structural factors that affect maternal outcomes, leveraging community
partnerships with a consortium of academic and non-profit institutions supporting positive
change in the Mississippi Delta.
Aim 1: Establish a meaningful and equal community partnership throughout the entire
research development and implementation process.
Aim 2: Ensure transparency and trust by employing community-centric strategies for
dissemination.
Aim 3: Adjust and adapt the center through a community-based model to make a lasting
contribution to women in the Mississippi Delta

Public health relevance
PUBLIC HEALTH RELEVANCE This proposal aims to establish the Jackson State University (JSU) - Mississippi Delta Research Center of Excellence for Maternal Health to address preventable maternal mortality, decrease severe maternal morbidity, and promote maternal health equity in partnership with the Mississippi Delta community. This research center will conduct two multi-layered research projects utilizing community health partners, inclusive of an extensive research training program for early-stage investigators, to address the interpersonal and structural factors that affect maternal outcomes. By establishing an equal partnership with the community in all parts of the process, we envision that this research center will overcome structural and interpersonal barriers to high-quality, culturally competent postpartum maternal care and ultimately improve maternal morbidity and mortality for women residing in the Mississippi Delta.